Admin Supplement for K08

PROJECT SUMMARY
Neonatal hypoxic ischemic encephalopathy (HIE), a common brain injury from loss of oxygen and
nutrients immediately prior to birth, results in long-term neurologic deficits even in the absence of significant
perinatal cell death. A major gap in the perinatal injury field is the limited mechanistic understanding of how
transient hypoxia results in persistent cellular deficits. A compelling mechanism linking prenatal hypoxia to
persistent deficits is that prenatal hypoxia permanently alters the epigenome because the epigenome integrates
development with response to the environment.
To study the mechanisms underlying the pathology of HIE, I developed a novel mouse model of transient
late gestation prenatal hypoxic injury that phenocopies mild HIE. Prenatal hypoxia leads to persistent behavioral
and structural deficits in adult mice despite no significant increase in cell death in the fetal brain. My preliminary
data showed decrease in dendritic spine density in corticothalamic neurons at postnatal day 28 (P28), weeks
after hypoxia. Prenatal hypoxia was associated with upregulation of genes associated with the epigenome in
single nucleus RNA and assay for transposase-accessible chromatin sequencing (snRNA/ATAC-seq) in the fetal
neocortex within one hour of exposure. One of the most upregulated genes, the histone variant H3f3b, is a
candidate for protecting the brain from more severe brain injury. However, the epigenetic trajectories of
corticothalamic neurons seemed to be shifted even immediately after hypoxic exposure. Therefore, my central
hypothesis is that H3f3b upregulation is necessary and sufficient to protect neurons from severe injury
after prenatal hypoxia and distinct epigenetic regulators contribute to lasting neuronal injury.
To test my hypothesis, I propose three aims. In Aim 1, I will use conditional knockout mice to test if H3f3b
depletion increases cell death immediately after hypoxia and worsens the persistent deficits in spine density in
P28 mice and behaviors in adult mice. In Aim 2, I will use in utero electroporation to test if overexpression of
H3f3b improves deficits from hypoxia in spine density in P28 mice and behaviors in adult mice. Lastly, in Aim 3,
I propose to use snRNA/ATAC-seq in the cortex of P28 mice to determine if prenatal hypoxia has a permanent
effect on the epigenome of corticothalamic neurons.
My long-term goal is to be a child neurologist who leverages my research expertise in molecular biology
and clinical skills in perinatal brain injury both to develop targeted therapies towards this frequently devastating
injury. My mentors, Drs. Eric Marsh and Michal Elovitz, are excellent physician scientists devoted to using
translational research to improving outcomes in children with neurological disorders. Under their guidance for
this K08 proposal, I will gain additional skills in bioinformatics, a deeper expertise in translational animal studies,
and lab management skills necessary to become an expert in the epigenetics of neurological disorders and be
prepared for a career as an independent R01-funded physician scientist.

Public health relevance
PROJECT NARRATIVE Neonatal hypoxic ischemic encephalopathy (HIE) is an injury to the developing brain that accounts for millions of years lived with disability worldwide and can be modeled in mice by transient late gestation prenatal hypoxia. Epigenetic modifying genes, like the histone variant H3f3b, are upregulated in the corticothalamic neurons of mice exposed to prenatal hypoxia. To gain insight into how epigenetic regulators may modulate outcomes after hypoxic insult, I will test if H3f3b protects developing neurons from more severe injury after prenatal hypoxia and if prenatal hypoxia persistently disrupts the epigenetic trajectories of corticothalamic neurons.